Line Scan Swept Source OCT (LS-SS-OCT)

PROJECT SUMMARY – LS-SS-OCT
The objective of this project is to develop a portable, low-cost line-scan swept-source
optical coherence tomography imaging system (LS-SS-OCT) for application in early
detection and monitoring of age-related macular degeneration (AMD), diabetic retinopathy,
and other eye diseases. The project addresses the recognized need for a more affordable
OCT system allowing the technology to be more widely adopted to reduce the prevalence of
AMD related vision loss and legal blindness by earlier detection of AMD in patients (earlier
screens) and more frequent monitoring of progression of AMD. Dry AMD, if not monitored
and treated appropriately, can progress into the wet form of AMD which is currently
responsible for more than 90% of the cases of legal blindness.

Public health relevance
NARRATIVE – LS-SS-OCT Diagnosing and monitoring the progress of age-related macular degeneration (AMD), which currently affects 196 million people world-wide, is of high importance for preventing severe vision loss and blindness. A compact, portable, low cost, optical coherence tomography (OCT) retinal imaging system will have a major impact on diagnosing and controlling AMD, diabetic retinopathy, and other eye diseases by earlier detection and closer monitoring helping millions of people to maintain vision into old age. To achieve this goal, we propose to develop an OCT system based on an innovative, simple swept source, line-scanning architecture that promises to reduce system cost and sales price by a factor of 5-10 (a critical advantage for world-wide availability) compared with existing clinical OCT systems without compromise in diagnostic performance.